Project 1- Elucidating oncogenic KRAS in PDAC cell signaling, resistance and immunity

Project 1 -­ Abstract/Summary
Oncogenic KRAS (KRAS*) is universally present in >90% of human pancreatic adenocarcinoma (PDAC) and
functions as the dominant driver for tumor development. The central theme of Project 1 has been the elucidation
of KRAS* function in PDAC and translate of these insights into effective therapies. In our previous grant cycles,
Project 1 and our P01 team have established the essential role for KRAS* in PDAC maintenance, prompting the
development of KRAS*-­targeted exosome-­based RNAi therapy from Project 3 that has been translated into a
first-­in-­human trial. Collaborative work from Project 1 and Project 2 has not only elaborated the regulation of
anabolic metabolism and nutrient salvage pathways that are essential for KRAS*-­driven tumor maintenance, but
also identified molecular and metabolism mechanisms leading to the resistance to KRAS* depletion. While these
studies elucidated the cancer cell-­autonomous regulation of KRAS*-­dependency in PDAC, recent studies from
Projects 1 and 3, further demonstrated the profound impact of KRAS* on the remodeling of the tumor
microenvironment (TME), a major hallmark of PDAC and barrier for effective therapies, including
immunotherapy. Specifically, we discovered a shift of myeloid infiltration in TME toward macrophages following
KRAS* extinction, which produce TGFBeta to support Kras*-­independent cancer cell survival growth. In depth
analysis of the TME further identified alternative immune checkpoints and demonstrated the importance of
myeloid cells in immune suppression, leading to the development of novel immunotherapy regimens with
unprecedented prolongation of survival in preclinical models. In this treatment study, we discovered a similar
shift toward monocytic myeloid lineage which may contribute to the resistance to combinatory immune
checkpoint inhibition. Therefore, in this next cycle, Project 1 will focus on elucidating the crosstalk between
KRAS* and the TME, focusing on monocytic myeloid cells, with the goal of translating these mechanistic insights
into effective new therapies. To achieve this goal, we will work closely with our innovative Cores, which have
extensive expertise in pathology, mouse modeling and computational biology, to conduct a systematic in vivo
genetic validation of the myeloid-­dependent KRAS* escape mechanism. These studies will be followed by
experiments to characterize the myeloid-­mediated resistance to the alternative immune checkpoint inhibition
regimen we have discovered. In the end, we will evaluate the anti-­tumor potential of blocking such myeloid-­
mediated resistance mechanisms in combination with novel immune checkpoint inhibitions. Our study will be
highly integrated with Project 2 to characterize the impact of signature PDAC mutations on TME-­mediated
KRAS* escape mechanisms. In addition, outcome from the proposed studies will be highly complementary to
the preclinical studies of Project 3 to deplete KRAS* in cancer cells with exosome-­based RNAi therapy, in
combination with rationally designed immune targeting strategies informed by findings from Project 1. The
knowledge gained from these highly integrated studies aims to inform future clinical trial opportunities.

Public health relevance
Project 1 - Project Narrative Pancreatic cancer is one of the deadliest cancer types in the United States with no effective therapy developed to date. During our previous funding cycles, this research project in close collaboration with our P01 team has elaborated the function of KRAS, the central driver for pancreatic cancer, and identified essential roles of the crosstalk between tumor cells and their environment for the support of cancer- relevant growth. In this next cycle, this project will continue to work with our Projects and Cores in a highly integrated fashion to perform in- depth studies on the role of the tumor immune microenvironment in the regulation of KRAS- dependence and response to immunotherapies, with a goal of rapidly translating our basic discoveries into clinical trials that will eventually benefit pancreatic cancer patients suffering from this dreadful disease.